Lung Cancer

PROJECT SUMMARY
The overall goal of the Lung Cancer (LC) Program is to improve lung cancer patient survival by optimizing early
detection strategies and developing novel therapeutic approaches for patients with late-stage disease, including
for small cell lung cancer patients. The fact that the number of deaths attributable to lung cancer in the US has
declined from 190,000 to 130,000 over the preceding decades provides reason for optimism on two fronts:
substantial reductions in cigarette smoke consumption, particularly in the US, have led to a decrease in the
number of lung cancer diagnoses; and five-year survival rates broke 20% for the first time for lung cancer
patients, strongly suggesting that novel treatments are meaningfully impacting the disease. Despite these
improvements in incidence and survival rates, these metrics compare very poorly to almost all other cancer
types. Underlying these dismal statistics reside two fundamental issues. First, our ability to identify lung cancer
at early states remains flawed, despite the introduction of legitimate screening practices. Second, our therapeutic
strategies for patients diagnosed at an advanced stage continue to leave much to be desired. These two
fundamental shortcomings must be addressed to produce a meaningful improvement in lung cancer patient
outcomes. Research from the program also addresses critical deficiencies in lung cancer care available to
patients residing within our catchment area. The LC Program has three specific aims to: 1) improve the efficacy
of immune based therapies for lung cancer patients, 2) implement effective strategies for lung cancer screening
and early detection, and 3) identify and exploit therapeutic vulnerabilities in SCLC. The program is a new program
for this Cancer Center Support Grant renewal and is led by a team spanning many aspects of lung cancer
research including basic, translational, population science, and clinical research in both non-small cell lung
cancer small cell lung cancer, as well as clinical expertise in thoracic oncology and pulmonary medicine. The
program is comprised of 34 members from Fred Hutchinson Cancer Center and the University of Washington,
the majority having dual appointments and bringing expertise in a diverse array of both lung cancer science and
lung cancer clinical care. Members hold $9.8M in research funding, including an NCI P50 Lung SPORE. The LC
program is a highly collaborative group; 19% of the 73 publications in the most recent 12-month reporting year
were intraprogrammatic and 33% were interprogrammatic. Twenty-two percent were in journals with impact
factors >10. Members are also actively engaged in national networks and cooperative groups.